A spatially resolved joint cortical metabolome and proteome in aging and menopause for the rhesus macaque

PROJECT SUMMARY / ABSTRACT
The preclinical phase of late-onset Alzheimer’s disease (LoAD) is a crucial time period for diagnosis and
intervention that is not well-modeled by the transgenic animal models commonly used in aging research. This
lack of strong models exists despite the fact that LoAD accounts for well over 90% of Alzheimer’s disease (AD)
cases and thus represents the bulk of the disease burden. At particularly high risk for LoAD are female carriers
of the ε4 apolipoprotein allele, a risk that has been linked to the menopause transition (MT). Macaque monkeys
well-model the preclinical phase of LoAD; this species recapitulates patterns of accumulation of amyloid and
tau pathology seen with aging in humans, and shows accompanying memory impairment equivalent to mild
cognitive impairment in humans. Furthermore, female macaques undergo the MT, and there is only one
macaque apolipoprotein isoform, equivalent to the human ε4 allele; all female macaques are therefore at high
risk for LoAD-like pathology. The macaque monkey thus offers a unique opportunity to study preclinical brain
changes in aging and LoAD, in a species with a brain that is structurally and functionally very similar to that of
humans. It has long been known that in humans during the preclinical phase of LoAD, amyloid and tau
pathology show characteristic sites of origin and (particularly for tau) patterns of spread; the mechanisms
behind these spatial features of the disease are not yet known. In order to understand the spatial
neurochemistry of the aging primate brain, we will study peri- and post-MT female macaques, and age-
matched male controls, delivering within-subject spatial atlases of metabolite levels (spatial metabolome),
protein expression (spatial proteome), and extant pathology for the cortex and cerebellum. The metabolome
and proteome will be obtained from the same samples, allowing trans-omic integration to understand spatial
patterns of biochemical pathway activity across the brain. The histopathological data will come from the
opposite hemisphere of the same individual. We will use spatial principal components analysis and a novel
spatial adaptation of multiple correspondence analysis to identify individual biomarkers and combinations of
biomarkers that account for spatial position in the cortex, and to identify biomarkers and biomarker
combinations that are associated with observed (in an individual) and predicted (from the literature) spatial
patterns of pathology. These crucial data will yield unprecedented insights into early aging and the critical
prodromal phase of LoAD, offering possibility of identifying biochemical factors that confer risk or resilience
upon local brain circuits. Factors promoting resilience are opportunities for intervention, while risk factors hold
the possibility for early diagnosis and screening; both of these outcomes will be crucial if we are to understand
and effectively address the most prevalent form of this devastating brain disease.

Public health relevance
PROJECT NARRATIVE The brain changes that accompany normal aging and Alzheimer’s disease do not occur at the same time or to the same degree in every part of the brain; instead they show a characteristic pattern in which some regions are affected to a much greater degree than are others. It is not known the extent to which these spatial patterns reflect differences in the local vulnerability between areas, nor the extent that they might reveal a mechanism by which pathology spreads. By measuring - across the entire cortex and cerebellum of aged individuals - the extent of pathological change, the patterns of brain inter connectivity, and local protein expression and metabolism we will test hypotheses about vulnerability and spread of Alzheimer’s pathology, opening the door to protective intervention.